Phase 1 First in Human Trial to Assess Safety and Tolerability of the Novel ACK1 Inhibitor (R)-9b in Patients with Prostate Cancer

Abstract
Prostate cancer (PC) is one of the leading cause of cancer deaths among American men. Advanced PC
patients often receive androgen deprivation therapy, but, the recalcitrant disease recurs within 2-3 years,
referred to as the Castration Resistant Prostate Cancer (CRPC). Androgen Receptor (AR) antagonists such
as enzalutamide (Enz) or abiraterone (Abi) are currently favored therapeutics for PC patients, however,
virtually all patients develop resistance. Post-CRPC state, therapeutic options for the recurrent disease are
limited. We discovered a non-receptor tyrosine kinase, ACK1, as a novel epigenetic modifier in prostate
tumors, regulating AR/AR-V7 expression. Enthused with these data, we developed a new class of ACK1
small molecule kinase inhibitor, (R)-9b. (R)-9b inhibits ACK1 and downregulates AR and prostate specific
antigen (PSA) expression to suppress prostate xenograft tumor growth. Moreover, in immune competent
mouse models, (R)-9b induces significant CD4+ and CD8+ T cell activation against syngeneic prostate
tumors. Employing ex vivo 3-D assays, we confirmed that (R)-9b functionally reinvigorates peripheral blood
mononuclear cells (PBMCs) of the CRPC patients to mount a robust immune response against human CRPC
organoids. Together, these data indicated that ACK1 inhibitor, (R)-9b with tumor-intrinsic and tumor-extrinsic
activities in the host tumor microenvironments is a novel class of inhibitor with much needed
immunomodulatory activity. Prolonged (R)-9b treatment exhibited normal histology suggesting that it is not
associated with toxicity, further underscoring the importance of targeting ACK1 to overcome resistance to
AR-targeted therapies. We have completed an extensive pre-Investigational New Drug (IND) studies
including pharmacokinetic, pharmacodynamic and metabolism studies in mouse/rat/canine models, which
revealed that (R)-9b possessed excellent drug-like properties. These data is submitted to FDA
(IND#167907). This proposal is directed towards phase I clinical trial for ACK1 inhibitor (R)-9b in CRPC
patients to examine its ability to overcome CRPC resistance by cytotoxic and immunomodulatory activity.
Specifically, we will:
Specific Aim 1: To assess the safety/tolerability, pharmacokinetics, and anti-tumor activity of (R)-9b in CPRC
patients
Specific Aim 2: To evaluate peripheral blood and tissue markers of anti-tumor and immune response after
(R)-9b exposure.
Overall, successful completion of this study will open a new therapeutic modality for CRPC patients who
have developed resistance for Enzalutamide and Abiraterone, which is a critical unmet need.

Public health relevance
Narrative Men with Castration-resistant Prostate Cancer (CRPC) do not respond to standard of care therapies or immunotherapy. To address this shortcoming, we developed a first-in-class ACK1 inhibitor, (R)-9b which not only suppressed AR/AR-V7 within the CRPCs tumors, but also activated the host immune response against tumors. The (R)-9b compound has shown good safety profiles in mouse, rat and canine models. This proposal is directed towards running the first-in-man Phase I clinical trial for (R)- 9b in CRPC patients. We will evaluate the safety, efficacy, tolerability and PSA levels in CRPC patients treated with (R)-9b. A successful Phase I trial should pave the way to Phase II/III clinical trials.